IMMUNONEUROENDOCRINE RESPONSE TO TETANUS TOXOID

The purpose of this protocol is to study the immunological and hormonal response to tetanus toxoid, an immunogenic stimulus, in people with Chronic Fatigue Syndrome and healthy volunteers.